Combinatorial Targeting of the Cell Cycle and Key Interacting Pathways in Mesothelioma

The Problem: Mesothelioma is a devastating cancer where the majority of patients will die from their disease.
The last significant advance in chemotherapy for mesothelioma was pemetrexed, which was approved by the FDA
in 2004. The vast majority of mesothelioma tumors have defects in the cell cycle. Low expression of the
CDK4/CDK6 inhibitor p16INK4a has been demonstrated in multiple basic and clinical studies of mesothelioma. A
phase III study reported a significant increase in survival in breast cancer patients who received palbociclib, a
selective CDK4/6 inhibitor. Mesothelioma tumors also exhibit activation of the PI3K/MTOR pathway, and inhibition
of PI3K/MTOR has been demonstrated to overcome CDK4/6 inhibitor resistance in breast cancer cells. A
decrease in reactive oxygen species (ROS) by mitochondrial antioxidant defense proteins plays a key role in the
ability of mesothelioma cells to overcome the pro-apoptotic signaling induced by ROS.
Knowledge to be Addressed: The long-term goal of this laboratory is to identify key principles of cancer
biology that will allow the appropriate selection of the most effective combination therapies based on upfront
molecular signatures. The objective of this application as a next step in the pursuit of this long-term goal is to
determine how targeting CDK4/6 may be exploited in combination with inhibition of CDK2, PI3K/MTOR, or
mitochondrial antioxidant defense in the treatment of mesothelioma. Findings will be correlated with mRNA
expression signatures that can be applied for to selecting treatment combinations for patients.
Hypothesis: Our central hypothesis is that inhibition of CDK4/6 in combination with inhibition of CDK2,
PI3K/MTOR, or mitochondrial antioxidant defense will cause cell death for multiple and distinct molecular subtypes
of mesothelioma.
Preliminary Studies: We have demonstrated that mesothelioma cell proliferation can be decreased via Cyclin
D1 knockdown and small molecule inhibition of CDK4/6. We have also demonstrated that gentian violet (known to
inhibit antioxidant defense) sensitizes mesothelioma cells to palbociclib in a synergistic fashion.
Specific aims: 1) Identify mechanisms by which CDK4/6 contributes to mesothelioma cell survival, determine
whether resistance to CDK4/6 inhibition varies by molecular subtype, and determine whether simultaneous
inhibition of CDK2 has synergistic benefits compared to inhibition of CDK4/6 alone. 2) Define the mechanism by
which PI3K/MTOR overcomes cell cycle inhibition and identify how the effectiveness of simultaneous inhibition of
CDK4/6 and PI3K/MTOR in mesothelioma varies by molecular subtype. 3) Identify mechanisms by which
inhibition of mitochondrial antioxidant defense and CDK4/6 individually or in combination affect mitochondrial
function and regulated cell death in mesothelioma cells.
Significance and Innovation: The proposed work is innovative because it capitalizes on evaluation of agents for
their ability to affect the cell cycle, PI3K/MTOR, or antioxidant defense in combination in mesothelioma based on
molecular profiling in a cancer known to be refractory to therapy. Based on the genomic profile of mesothelioma,
using cell cycle inhibition as a component of combination therapy should be ideal. The proposed research will lay
a groundwork for how cell cycle inhibitors can be given in combination with inhibitors of CDK2, PI3K/MTOR, or
mitochondrial antioxidant defense. A very positive translational impact of this work is that it will inform the design of
clinical trials for testing CDK4/6 inhibitors in combination with other active cancer-fighting drugs.

Public health relevance
Mesothelioma is devastating to Veterans. Inadequate therapies exist for the treatment of mesothelioma, as the median survival for treated metastatic mesothelioma is approximately one year. Many Veterans were exposed to asbestos via shipbuilding. Ongoing studies suggest that the incidence of mesothelioma is not declining. This may be in part due to issues with exposure to asbestos fibers via mining. Carbon nanotubes have been shown to induce mesothelioma in mice. Many people who develop mesothelioma have significant co-morbidities that preclude aggressive treatment. The last FDA approval for a new drug for mesothelioma was in 2004. Improvement in the understanding and simultaneous targeting of the cell cycle in combination with the inhibition of other cellular pathways based on precision oncology-based techniques is a promising, novel, and exciting approach to discovering new and better tolerated therapies for mesothelioma. This project will provide information critical for development of future therapies for mesothelioma and other cancers.